Function of GATA3-PARP1 complex in breast cancer during GATA3-mediated cellular reprogramming

Project Summary
GATA3 is a transcription factor that acts as a pioneer factor in breast cancer cells. However, the function of
pioneer factors isn’t well understood. Specifically, how they activate silent chromatin is largely
unknown. The long-term goal is to provide novel insights into the molecular mechanisms of pioneer factor-
mediated cellular reprogramming at a chromatin level.
More than 7 million GATA3 motifs exist in the human genome, but the experimental data from GATA3 ChIP-
seq analysis indicates less than 1% of the motifs are occupied by the pioneer factor, GATA3. In addition to
binding selectivity, pioneer factor action, including GATA3, is known to be site-specific (context-dependent),
and they can only induce chromatin opening and enhancer formation at a subset of binding sites. The overall
objective of this proposal is to identify the binding specificity of the pioneer factor, GATA3, in the genome and
elucidate the impact of the interaction between GATA3 and chromatin-modification enzyme, Poly ADP-ribose
polymerase 1 (PARP1), on gene activation. Our preliminary data strongly suggest that PARP1 is involved in
such context-dependent action of GATA3. The central hypothesis is that GATA3-mediated cellular
reprogramming is dependent on the PARP1 activity. The rationale for this study is that the identification of
the roles of GATA3 and PARP1 interaction will provide novel molecular mechanisms underlying the site-
specific expression of pioneer factor activities during cellular reprogramming. The central hypothesis will be
tested by (1) investigating the function of PARP1 in the binding selectivity of GATA3 and (2) identifying the
role(s) of GATA3-PARP1 interaction in gene activation. To test this hypothesis, I will use our unique DOX-
inducible system in MDA-MB-231 basal breast cancer cells. In this system, exogenous GATA3 expression
initiates mesenchymal-to-epithelial transition (MET). This system recapitulates GATA3 function in patient
breast tumors since GATA3 expression is known to be higher in the luminal/epithelial breast tumors, and is
essential for the maintenance of epithelial phenotypes. Under the first aim, we will investigate changes in
GATA3 binding across the genome in the presence and absence of PARP1. The second aim will utilize next-
generation sequencing to evaluate the effects that GATA3 and PARP1 have on the steps in pioneer factor-
mediated cellular reprogramming. The proposed research is innovative because we are addressing the novel
concept of context-dependent enhancer formation by a pioneer factor during cellular reprogramming.
This research is significant because it will fill a critical gap in our knowledge about how pioneer factors mediate
cell fate transition.

Public health relevance
Project Narrative Pioneer factors are mutated in various tissues and in immune cell pathways, thus underscoring their importance in development and disease. This project will investigate how pioneer factors mediate cellular reprogramming, specifically by probing the mechanism(s) behind their chromatin opening activity and learning how they recognize binding sites within closed chromatin. These studies will shed light on understanding the function of pioneer factor GATA3 in breast cancer cells.